DEPRESSION AS A RISK FACTOR FOR ISCHEMIC HEART DISEASE

This protocol did not begin to admit patients during this reporting period. It utilized the biostatisticians for for protocol design, analysis and interpretation of data, and preparation of manuscripts and grants. Citations are included in the Publications section.